Leveraging Large-Scale Multi-Ethnic, Multi-Omic Data for Functional Analysis of Central Obesity Loci

PROJECT SUMMARY
Obesity, defined as an abnormal or excessive accumulation of fat, is a major risk factor for many chronic diseases
(heart disease, stroke, diabetes, osteoarthritis, some cancers) and is associated with increased morbidity,
mortality, and health care costs. Rates of obesity have been increasing worldwide, nearly tripling since 1975.
Central obesity (e.g., waist-to-hip ratio [WHR], WHR adjusted for BMI [WHRadjBMI], and/or waist circumference
[WC]) is more strongly associated with detrimental body fat accumulation and is a better predictor of
cardiovascular disease (CVD), type 2 diabetes (T2D), and mortality than BMI. Genetic factors play a major role
in central obesity, based upon genome-wide association scans (GWAS) and fine mapping having established
hundreds of loci, with associated variants located in non-coding regions of the genome and, therefore, are
predicted to regulate gene expression. The target gene(s) that impact biologic pathways may not be the gene(s)
closest to the associated SNPs. In order to identify putative causal central obesity genes, we will identify
expression quantitative trait loci (eQTLs) and protein quantitative trait loci (pQTLs) using multiple methods of
colocalization, Mendelian randomization, and Bayesian networks applied to data from nine longitudinal studies
in the NHLBI TOPMed (Trans-Omics for Precision Medicine) program. These studies will provide diverse genetic
ancestry and multiomic data (whole genome sequence, transcriptomic, and proteomic) that will establish a
priority list of genes. Combining evidence from multiple independent analysis approaches with multiomics data
will be critical to link central obesity GWAS variants to putative target genes. The prioritized central obesity genes
will be validated using in vitro (human cells) and in vivo (diet-induced mouse) models of human obesity. We will
use cultured adipocytes from male and female donors of European- and African-ancestry as an in vitro model
and perform gene silencing and overexpression for metabolic impact on adipocyte functions relevant to central
obesity. Measures of in vitro effects will guide gene selection for in vivo testing of male and female mice using
high fat diet-induced model of human obesity. The in vivo model uses an adeno-associated viral (AAV) construct
overexpressing the gene under control of the Adipoq promoter/enhancer (with control having an AAV encoding
eGFP) that will provide longitudinal metabolic measures and adipose tissue-derived assessment of cellular and
molecular effects. The analyses of multiomics data coupled with in vitro and in vivo experimental results will
nominate and validate central obesity genes. This research will increase our understanding of genes and biologic
pathways contributing to the development of central obesity, thereby linking human GWAS findings to targeted
interventions and therapeutics in obesity.

Public health relevance
PROJECT NARRATIVE Obesity, and specifically central obesity (e.g., waist-to-hip ratio, WHR) rather than body mass index (BMI), is a major contributor to cardiovascular disease, type 2 diabetes, and early morbidity and mortality in the United States, with greatest impact on those individuals of African and Hispanic/Latino genetic ancestry. Here, we will identify genes associated with central obesity using multiple analytic approaches to prioritize potential therapeutic targets based upon nine longitudinal studies with genomic, transcriptomic, and proteomic data generated in the NHLBI Trans-Omics for Precision Medicine (TOPMed) program. Prioritized central obesity genes will be validated using experiments in human cells (in vitro) and in a high fat diet-induced mouse model (in vivo) of human obesity, thereby building evidence of genes having a role in central obesity.